Lymphatic Dysfunction and Development of Post-Transplant Obliterative Bronchiolitis

PROJECT SUMMARY
The etiology of bronchiolitis obliterans syndrome (BOS), a serious complication that affects the terminal airways of the
transplanted lung and is the main cause of long-term graft dysfunction and failure after lung Tx, is unknown. We
hypothesize that loss of lymphatic function after lung Tx is critical to the development and progression of BOS and,
post-reconstitution is affected by disruption of interactions between lymphatic endothelial cells (LECs) and Foxp3+
T-regulatory (Treg) cells. This hypothesis is based on our preliminary data.
First, using orthotopic murine models of lung Tx, we have shown that deletion of lymphatics (loss of function, LOF) within
the transplanted lung leads to acute inflammation and promotes BOS, as does conditional deletion of lymphotoxin-beta
receptor (LTbR) within LECs. Second, we found stimulation of lymphangiogenesis in a gain of function (GOF) model
involving conditional deletion of the lipid phosphatase, Pten, can protect against BOS. Third, adoptive transfer of LTb+ but
not LTb- Treg cells can protect against lung injury and the development of BOS post-Tx.
Specific Aim 1. Determine the mechanisms of lymphatic vascular function after lung Tx. Hypothesis: Lymphatic
function post-Tx is mediated by immunomodulatory adaption of donor LECs and signaling via the LTbR/LTa1b2 axis.
Using lymphatic reporter mice, i) we will determine the contribution of donor versus host-derived LECs to the lymphatic
vasculature post-Tx. ii) We will also map LEC heterogeneity and subtypes that define the lymphatic vascular adaptation in
lung Tx. Finally, iii) we will use mice deficient in LTbR, LTa or LTb to determine the mechanistic role of these pathways
in lymphatic function post-lung Tx.
Specific Aim 2. Strategies to promote lymphangiogenesis in the lung Tx. Hypothesis: GOF strategies to promote
lymphangiogenesis within the transplanted lung will protect against the development of BOS. This will involve 3
independent lines of investigation, i) administration of an agonistic mAb directed against LTbR expressed by LEC; ii)
delivery of recombinant VEGF-C by AAV; and iii) blockade of epsins to reduce VEGFR3 endocytosis and degradation and
thereby increase VEGFR3 protein expression and promote lymphangiogenesis.
Specific Aim 3. Strategies to promote CLAD-free Treg-dependent lung allograft survival. Hypothesis: Therapeutic
strategies that enhance endogenous Treg numbers and/or function will promote CLAD-free Tx survival. Accordingly, we
will test the ability of therapy with i) IL-2 muteins alone or ii) in conjunction with Cdk8/19 inhibitors (Cdk8/19i) to expand
the recipient Foxp3+ Treg cell population and promote beneficial outcomes in lung Tx models; and iii) assess whether
Foxp3 mRNA delivery can likewise expand the host Treg population and promote lung allograft survival.
Our proposed research will unravel the complex interactions between lymphatics, host immune responses, and the
development of key complications of lung Tx, with the ultimate goal of improving patient outcomes and long-term lung Tx
survival.

Public health relevance
PROJECT NARRATIVE We have found that the normal distribution of intra-lung lymphatics is disrupted during lung transplantation and takes some weeks to be reconstituted; in addition, acute lung injury can develop during this period and further affect lymphatic reconstitution. We propose that pulmonary lymphatic injury can predispose to subsequent development of chronic lung allograft dysfunction (CLAD), a major cause of morbidity and mortality in lung transplant recipients. We propose studies to explore interrelationships between Foxp3+ Treg cells and lymphatic endothelial cells and identify their potential roles in protection against development of CLAD.